Molecular toolkit for high content resolution of glycomes by expansionmicroscopy

Project Summary/Abstract
Carbohydrate chains, known as glycans, are fundamental to a wide spectrum of biological processes, including
anticoagulation, cell growth and development, cell-cell communication, immune recognition/response, and
microbial pathogenesis. Glycans also feature prominently in human disease, including the majority of human
cancers. The spatial arrangements of glycans on the cell surface are now recognized to inform life’s most critical
cellular and multicellular behaviors, including growth, cell fate transitions, and tissue assembly. Thus, the
underlying hypothesis of the proposal is that a better understanding of the role that glycans play in both health
and disease could be achieved with a comprehensive set of molecular tools for imaging the glycome with high
spatial resolution. Recent years have witnessed the emergence of powerful new approaches for optical imaging
at nanometer lengths scales. One revolutionary approach, called expansion microscopy (ExM), achieves ultra-
detailed structural imaging by swelling samples in a polyelectrolyte matrix so that nanoscale features can be
resolved on conventional fluorescence microscopes. Unfortunately, these approaches have yet to be harnessed
for advancement of glycobiology due to a lack of compatible imaging reagents that specifically recognize
biologically important glycan epitopes (glycotopes) and that are customized for advanced super-resolution
microscopy methods including ExM. To address these challenges, this proposal seeks to create an imaging
technology called glycoconjugate ExM (GlycoExM) that leverages multifunctional chemical probes and
glycotope-specific affinity reagents for facile detection and nanometer resolution of cellular glycans and
glycoconjugates. (Aim 1) A suite of multifunctional chemical probes based on multifunctional
oligothioetheramides (oligoTEAs) will be developed for untargeted GlycoExM imaging of metabolically labeled
glycans on widely available confocal microscopes with up to 15 nm effective resolution. (Aim 2) A method for
isolating custom affinity reagents from non-immune libraries will be adapted for multiplexable selections of
glycotope-specific antibodies (glycobodies). (Aim 3) Glycobodies will be optimized for targeted GlycoExM
through protein engineering and oligoTEA conjugation, leading to reagents that will enhance the resolution of
ExM for cells and tissues. Detailed protocols will be developed for the top performing reagents and will include
information on renewable biosynthesis of glycobodies, optimal reagent concentrations, and validated imaging
conditions. In addition to the development of this reagent “operator’s manual,” the project will also use oligoTEAs
and glycobodies to probe the spatial expression of authentic glycan signatures on the surfaces of different normal
and cancer cell lines to, for example, provide (1) super-resolved maps of immunomodulatory glycans in the
glycocalyx and (2) the first detailed molecular structure of the putative galectin lattice. Overall, the proposed
GlycoExM platform has the potential to enable high-content imaging on a glycome-wide scale, while the low-cost
and user-friendliness will ensure that it becomes broadly accessible to the glycoscience community and beyond.

Public health relevance
Project Narrative Unraveling the ‘sugar code’ that underlies the structure and biological function of glycans and deciphering how glycans encode spatial information could open the door to new opportunities for programming cellular behaviors on demand and attenuating disease processes. However, high content resolution of the “spatial” glycan code remains a daunting task in large part due to the inherent structural complexity of glycans and glycoconjugates, the current lack of affinity reagents for their specific recognition, and the challenge of visualizing glycan arrangements at the requisite nanometer length scale. To address this grand challenge, the objective of the proposed studies is to create a robust, integrated pipeline for rapid development of chemical probes and selective, high-affinity antibodies that are custom tailored for super-resolution imaging using expansion microscopy, thereby enabling ultrastructural investigation of the spatial expression of glycans and glycan-polypeptide determinants in cells and tissues. ! ! !